Predictive models for incident cirrhosis in non-alcoholic fatty liver disease using genetic and electronic medical record-based risk factors

Project Summary/Abstract
Non-alcoholic fatty liver disease (NAFLD) affects >80 million people in the United States and is implicated in
up 36% of liver-related deaths. While NAFLD is the fastest-growing cause of cirrhosis and liver-related
complications, not all patients with NAFLD ultimately develop cirrhosis. Our ability to identify which patients
are at highest risk is limited, which makes it challenging to allocate intensive lifestyle intervention and
pharmacologic therapy to those at highest risk. The strongest predictor of incident cirrhosis is fibrosis stage,
but existing fibrosis only identifies patients who have already progressed toward cirrhosis and requires
advanced phenotyping such as biopsy or transient elastography which are not universally available. It will be
critical to develop improved models for disease progression. This project focuses on two factors which may
improve risk stratification of progression to cirrhosis: genetics and machine learning using electronic medical
record (EMR) data. Heritability of liver fibrosis and cirrhosis is as high as 50%, and a number of genetic
variants have been linked to risk of cirrhosis. The EMR is a rich but complex source of data used in clinical
practice. When constructing models with such high-dimensional data, non-linear effects and interactions
between predictors are common; machine learning algorithms may outperform the more commonly-used
logistic regression models in this respect. The overall goal of this project is to generate predictive models for
which patients with NAFLD are most likely to progress to cirrhosis by integrating genetics and EMR-based
predictors with machine learning. The specific aims are (1) characterizing the effect of genetic risk factors on
rate of progression from NAFLD to cirrhosis, (2) training and validating machine learning models for incident
cirrhosis based on EMR data, and (3) generating integrated models incorporating both EMR and genetic data.
To accomplish these aims, Dr. Chen will obtain further training in processing of EMR data, the fundamentals
of statistical genetics, and machine learning and predictive modeling. Dr. Chen’s long-term goal is to become a
leading, independent investigator generating models to predict outcomes in NAFLD and eventually even
prioritize patients for treatment accordingly. An NIDDK K08 award will provide Dr. Chen with the necessary
time and training to achieve his career goals and improve care for patients with NAFLD. Overall, this project
will improve ability to predict which patients with NAFLD are most likely to develop cirrhosis and therefore
enhance precision health by helping medical providers prioritize persons at highest risk to more intensive
intervention.

Public health relevance
Project Narrative Non-alcoholic fatty liver disease (NAFLD) affects >30% of the US population and is projected to become the leading cause of liver-related death in the US within the next 20 years; however, predicting which patients with NAFLD ultimately develop advanced liver disease is challenging and this knowledge gap impairs allocation of resources to the highest-risk patients. Genetics and electronic medical record-derived data may provide additional information that assists with risk stratification, and the research proposed here will incorporate genetics with the electronic medical record to generate predictive models for incident cirrhosis among patients with NAFLD. Ultimately, this project will allow medical providers to better identify which patients with NAFLD are at highest risk of progression and accordingly prioritize them for intensive therapy.